Improving statistical inference when interest focuses on the identification of extreme random effects in clustered data

PROJECT ABSTRACT
Statistical models that generate predicted random effects are widely used to evaluate the status of and rank
patients, physicians, hospitals and health plans from longitudinal and clustered data. Predicted random effects
have been proven to outperform simpler approaches such as standard regression models, on average.
These predicted random effects are often used to identify extreme or outlying values, such as elderly patients
with rapid declines in their health or poorly performing hospitals. When interest focuses on the extremes rather
than performance on average, there has been no systematic investigation of best approaches. We propose to
develop novel methods for prediction of extreme or outlying values and systematically evaluate their performance
using theoretical calculations, simulations and examples.
Merely predicting extreme or outlying values is rarely sufﬁcient and decision rules for identifying extreme
values in a statistically rigorous manner are also needed. We will develop such approaches and provide easy-
to-use software to implement the recommended methods.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to develop new statistical approaches for the identiﬁcation of patients, hospitals, physicians or health plans that are extreme as judged on the basis of a metric such as rapid cognitive decline for patients or very high readmission rates for hospitals. Using theoretical calculations, simulations and examples we will develop statistically rigorous methods for predicting and identifying extreme values and provide easy-to-use software to implement the proposed methods.